Appalachian and Great Lakes Research Biospecimen Resource (AGL-RBR) of the Cooperative Human Tissue Network (CHTN)

PROJECT SUMMARY/ABSTRACT
This proposal organizes the resources and experience of the Appalachian and Great Lakes Research
Biospecimen Resource (AGL-RBR) for participation as an Adult Division of the NCI Cooperative Human Tissue
Network (CHTN). Our AGL-RBR group of pathologists is equipped to efficiently provide remnant patient
consented biospecimens for basic and early translational cancer research as well as for biomarker research
studies to support personalized medicine. The Ohio State University (OSU) Hospital and James Cancer
Hospital in Columbus, OH will function as the Coordinating/Procurement Center while University Hospitals
Cleveland Medical Center, Cleveland, OH, University at Buffalo hospital affiliations, Buffalo, NY and University
of Pittsburgh Medical Center Shadyside, Pittsburgh, PA and associated hospitals will function as
geographically distributed Procurement/Biorepository sites. The OSU Coordinating Center- Investigator
Management Service will manage the investigator applications and approvals and investigator biospecimen
request networking. The OSU Biospecimen Management Service will handle the tissue Quality Control,
biospecimen storage and shipping and CHTN fee billing, collections and monthly accounting. Tissue
Procurement supports custom biospecimen collection including investigator provided novel preservation fluids
or methods. Available informatics support collection of data related to donor consents, biospecimens,
investigators and billing. Shipped biospecimens include a redacted Pathology and QC Report for each
biospecimen shipped. Pathology Reports at OSU for freshly procured tissues include clinically appropriate
molecular testing. Investigators may also request, if IRB approved, extensive clinical data available from the
OSU Information Warehouse (IW) and additional laboratory testing such as immunohistochemistry, tissue
microarray construction, digital microscopy or digital morphometrics. Biospecimen donor privacy and
confidentiality are essential elements of the AGL-RBR biospecimen management proposal so that all procured
biospecimens are patient consented and coded. Delinking is available for special tissues that were not
consented at procurement. The OSU procurement program joined the OSU Comprehensive Cancer Center
(OSUCCC) in deploying the Total Cancer Care® (TCC) protocol in 2016 to provide comprehensive donor
consent. Donors who consent give full use for future research all of their past, present and future remnant
biomaterials to IRB approved researchers. Procurement/Biorepository sites have similar consent programs in
place. Scientific or technical knowledge or discoveries acquired in the conduct of our tissue
procurement/preservation program will be reported at national and international scientific and technical
meetings to contribute to the growth of biospecimen science, to recruit new investigators who have research
interests best served by human biospecimen research and to inform the research community and public.

Public health relevance
PROJECT NARRATIVE Cancer is an often deadly disease without universal treatment options, but new discoveries can lead to new cancer treatments to the benefit of all. Progress is dependent on good scientific ideas supported by high- quality novel resources so that investigators can ask and answer critical research questions. Our proposed Appalachian and Great Lakes Research Biospecimen Resource (AGL-RBR) will respond to the cancer researcher's ever-changing challenges by supporting them with custom prepared high quality human tissues and biofluids enriched by innovative clinical data sets.